Fertility legislation and unmet needs: Exploring intervenable barriers for quality oncofertility care among adolescent and young adult cancer patients

PROJECT SUMMARY/ABSTRACT
Curative cancer treatment modalities (e.g., chemotherapy) are gonadotoxic (i.e., destroy sperm and eggs) and
frequently cause infertility. Thus, clinical practice guidelines intended to facilitate optimal oncofertility care
indicate that oncologists should comprehensively discuss possible treatment-related infertility with all cancer
patients of reproductive age. Such discussions are particularly relevant for adolescent and young adults (AYA;
15-39 years) with cancer who are in the prime of their reproductive years and endorse fertility-related distress
following treatment, situating oncofertility as a priority research area for AYAs. Unfortunately, barriers to
the implementation of guidelines compromise their effectiveness and AYAs are infrequently informed of
fertility preservation options, with knowledge, cost, and insurance barriers hindering uptake of preservation
among AYAs. The cancer care continuum is a multilayer system that describes a hierarchy of intervention
levels that are influential in cancer care delivery. Oncofertility care is particularly amenable to intervention at
various levels of influence (e.g., provider/team, organization/practice setting, health policy), as patient-,
provider-, system-, and policy-level factors impact the delivery and uptake of optimal care. Thus, I aim to
investigate oncofertility among AYAs by examining the multilevel influences of the cancer care
continuum. Most existing AYA oncofertility research is focused on clinical samples (e.g., academic medical,
comprehensive cancer centers) and on non-Hispanic white patients, limiting generalizability of findings, lacking
ethnic and racial diversity, and likely not capturing the experiences of at-risk AYAs. To address these gaps, my
dissertation (F99 Phase) will use SEER data to comprehensively examine oncofertility among a diverse,
population-based sample of AYAs to improve external validity and capture the care experiences of the
underlying population. I will gain an understanding of (F99 Training Goal 1) clinical considerations of fertility
issues, (2) quantitative analysis of cancer registry data, and (3) qualitative research methods to (F99 Aim 1.1)
examine sociodemographic and (Aim 1.2) healthcare correlates of AYAs’ fertility experiences (fertility
discussion, preservation, family planning, reproductive concern) and will (Aim 1.3) explore barriers/facilitators
to delivering guideline-concordant fertility discussions for AYAs among providers. To examine environmental
influences on oncofertility care, (K00 Phase) I will seek a postdoctoral position to study (K00 Training goal 1)
implementation science and intervention research and (2) health policy to examine (K00 Aim 2.1) provider
perceptions and perceived actionability of fertility guidelines and (Aim 2.2) insurer adherence to legislative
mandates and barriers to coverage for preservation. AYAs should receive equitable and guideline-
concordant care to improve reproductive outcomes. Therefore, understanding the multilevel influences
impacting oncofertility is critical to develop actionable, evidence-based interventions that improve care and
ensure AYAs are not disproportionately affected by their cancer experience.

Public health relevance
PROJECT NARRATIVE Many cancer treatments are gonadotoxic and have a high likelihood of subsequent infertility, placing comprehensive fertility care at the forefront of quality care delivery to ensure that adolescent and young adult (AYA) patients are not disproportionately affected by their cancer experience. Understanding the multilevel influences across the cancer care continuum, including patient-, provider-, system-, and policy-level factors, is critical to effectively improve oncofertility care and create optimal long-term outcomes. My dissertation research will use cancer-registry data to characterize the fertility experiences of ethnically diverse AYAs and will qualitatively explore barriers/facilitators to guideline-concordant fertility discussions among cancer care providers, while my postdoctoral research will extend this work to investigate provider implementation and perceived actionability of fertility guidelines and insurer adherence to legislative mandates and barriers to covering fertility preservation through insurer perspectives.